Necessity of RNA degradosome assembly in Sinorhizobium meliloti for effective symbiosis

Project Summary / Abstract
The proposed project will elucidate how subcellular compartmentalization of the RNase E
endonuclease into bacterial ribonucleoprotein granules (BR-bodies) in Sinorhizobium meliloti contributes to
successful host colonization. S. meliloti serves as a model for investigating infection by alpha-proteobacteria,
which include human pathogens such as Brucella, Bartonella, and Rickettsia. Understanding the molecular
and cellular mechanisms that underpin effective host colonization can provide critical insights for preventing
and treating infectious diseases, particularly as bacterial resistance to antibiotics continues to emerge.
S. meliloti establishes mutualistic symbiosis with compatible legumes, including the genetically tractable
reference species Medicago truncatula, by inducing development of root nodules, colonizing them, and fixing
nitrogen in exchange for nutrients from host plants. We found that removing the C-terminal intrinsically
disordered region of RNase E in S. meliloti led to ineffective symbiosis, eliciting nodule development but
producing etiolated plants that grew poorly compared to plants inoculated with wild-type bacteria. RNase E is
an essential ribonuclease involved in RNA processing and decay, and its C-terminal domain, while dispensable
for viability, was shown to be necessary and sufficient for the formation of liquid-liquid phase-separated
biomolecular condensates, named BR-bodies, in alpha-proteobacteria. Sequestration of RNase E into such
BR-bodies facilitates mRNA decay and modulates the cellular RNA pool. The goal of this project is to
determine how phase separation of RNase E influences RNA processing in S. meliloti and enables effective
symbiosis by accomplishing the following three specific aims. (1) We will assess the symbiotic defects of the
RNase E C-terminal deletion mutant in detail by genetic analysis. (2) We will use microscopy to characterize
the role of BR-bodies during host colonization. (3) We will examine how transcriptomes differ between wild-
type and mutant S. meliloti during symbiosis, as well as compare gene expression profiles of host plants
colonized by wild-type versus mutant bacteria. While RNase E has been linked to pathogenesis of various
bacteria, including Brucella, relatively little is known about the specific microbe-host interactions involved.
Results from the proposed investigation will help identify and provide better understanding of genetic and
cellular factors that allow infecting bacteria to bypass host defenses.
In addition to accomplishing the scientific objectives described above, this proposal will allow students,
particularly those from underrepresented backgrounds, to gain research training and preparation for biomedical
careers.

Public health relevance
Project Narrative The proposed research aims to unveil molecular mechanisms that enable bacterial cells to infect and colonize their host organisms. Results from the investigation will provide insights into microbe-host interactions, both beneficial and harmful, and ultimately improve the prevention and treatment of microbial diseases. In addition, the project will provide immersive research experiences for students, particularly those from traditionally underrepresented backgrounds, and encourage their pursuits of biomedical careers, thus strengthening the workforce pipeline in health-related fields.